Vascular injury and repair predict divergent late onset cardiovascular morbidities after chlorine and sulfur mustard exposure

PROJECT SUMMARY - R01 (Veress)
Inhalation of sulfur mustard (SM) at high doses causes acute cardiopulmonary failure from a hypercoagulable
state within the lungs, presenting as acute airway obstruction by fibrin airway casts. Acute and early systemic
hypercoagulability also occurs, resulting in macro- and microvascular thrombosis within at least the pulmonary
vessels, and likely other organs as well. However, most people who are exposed to SM inhale a lower dose of
SM, resulting in minimal acute symptoms and acute fatalities. Nevertheless, their SM inhalation exposures
results in the development of significant pulmonary morbidities, including delayed, long-term (often progressive)
cardiovascular sequelae months to years after the acute exposure event. These late-onset morbidities from SM
inhalation include chronic lung diseases, and chronic progressive cardiovascular diseases, such as pulmonary
hypertension (PH), arterial hypertension (HTN) and cardiac dysfunction/failure. These disorders decrease
quality of life for survivors, have no cure, and their pathogenesis are poorly understood. Conversely to SM, high
dose chlorine (Cl2) inhalation is only fatal within a few hours after exposure, due to severe epithelial and airway
edema, severe acute nervous system dysfunction, abnormal calcium storage/release, and acute
vasoconstrictive pulmonary hypertension (PH). No acute fibrin casts form in the airways with Cl2, and intriguingly,
recovery after Cl2 exposure does not result in any long-term cardiovascular morbidities. Mechanisms that protect
from development of chronic cardiopulmonary diseases after Cl2 gas is of high interest. We developed,
characterized and validated two relevant recovery models of SM and Cl2 inhalation in Sprague Dawley rats (LD50-
28d), both of which mimic the human recovery syndrome after these injuries. Preliminary data show that rats
exposed to low dose SM inhalation develop not only late pulmonary fibrosis, but also significant progressive
(worsening over time) PH, RV dysfunction, cardiac failure, and increased systemic arterial resistance late (>14-
21 days) after exposure – as measured by rat echocardiography and hemodynamics techniques. Additionally,
we found that after acute recovery from exposure to Cl2 inhalation, a complete cardiovascular recovery occurs
by 29 days (or earlier). Proteomics pathway analysis and histopathologic studies from 29 days after SM inhalation
indicate significant ongoing endothelial cell pathway dysfunction, cardiomyocyte/myocyte pathway dysfunction,
and continued coagulation abnormalities past the acute recovery phase. We hypothesize, that continued
endothelial cell dysfunction during recovery following SM but not Cl2 inhalation will trigger persistent pro-
coagulant and pro-remodeling pathways within the lungs, heart and systemic vasculature, and that this will result
in the development of chronic thrombosis and myofibrillar hypertrophy, leading to late-onset chronic progressive
pulmonary arterial dysfunction (PH), systemic vascular dysfunction (HTN), and cardiac ventricular dysfunction
and failure. This proposal will develop hits for future therapeutic development against chronic cardiovascular
sequelae of SM inhalation.

Public health relevance
PROJECT NARRATIVE Inhalation of toxic chemicals often causes late development of high blood pressures within the lungs for unclear reasons, leading to significant breathing difficulties, heart damage, and sometimes even death. In this project we will study two chemicals that injure the lungs after direct inhalation, but where only one of those chemicals causes late-onset high blood pressures in the lungs, while the other results in normally recovered lungs within days. We will investigate a possible reason for developing such high lung blood pressures, by studying the abnormal healing of the blood vessels that support the lungs. The findings of this application will improve our understanding of late-onset blood vessel problems after chemical inhalation, and will lead to the new medication testing in the future.